Conference--Cell &Molecular Biology of Bones and Teeth

DESCRIPTION: (The Gordon Research Conference on the Cell and Molecular Biology of Bones and Teeth is now in its 46th year. The Conference has a history as a proving ground for new ideas in the field of skeletal research and the study of calciotropic hormones and how they relate to bone biology. The Conference is said to be unique in the breadth and depth of its coverage of new developments in the physiology and molecular biology of cartilage, bones, and teeth. The Gordon Research Conference format provides an opportunity for open, free, and informal discussion, discussion which brings together international leaders in the field, young investigators, postdoctoral fellows and students. These characteristics of the Gordon Conference are attributable to their limited size, geographical isolation and overall structure. The 2001 Conference will focus exclusively on areas in which important new developments have occurred within the past two years. It will include sessions on Calciotropic hormones; Nuclear receptors role in bone; Extracellular matrix proteases; Transcription control of osteoblast and chondrocyte differentiation; the role of secreted molecules in skeleton biology; Craniofacial development and Limb patterning. The purpose of this application is to request funds to partially defray the costs of speakers' transportation and subsistence.